Scaling-up Medication for Opioid Use Disorder in Residential Treatment Settings

PROJECT SUMMARY/ABSTRACT
Medications for opioid use disorder (MOUD; methadone, buprenorphine, naltrexone) are highly efficacious
treatments for OUD; risk of fatal and nonfatal overdose is significantly reduced during their use. However,
MOUDs are vastly underutilized, and MOUD adoption is particularly low in residential treatment programs
(RTPs). Individuals with OUD are particularly vulnerable to overdose directly following discharge from controlled
environments such as RTPs when tolerance is greatly diminished. RTPs therefore represent a novel touchpoint
for initiating MOUD treatment for individuals with OUD, and additional research is urgently needed to identify key
factors that support scaling-up of MOUD in these settings. Recent policy changes by the Centers for Medicare
and Medicaid Services (CMS) allowed state Medicaid programs to reimburse services delivered in Institutions
for Mental Disease (IMDs; “IMD waiver”), i.e., RTPs with 16 or more beds, and required RTPs ensure access to
MOUD. This presents a unique opportunity to study MOUD adoption in RTPs and learn about the factors that
support its uptake by a particularly vulnerable population, Medicaid beneficiaries with OUD. The overall goal of
this K-99/R-00 Pathway to Independence application is to supplement the candidate’s existing skillset by
providing structured, intensive training in implementation science frameworks and study design, integration and
analysis of large data sets to study state policies targeting adoption of evidence-based addiction treatment, and
career development activities during the K-99 phase of the award. This training will take place in an outstanding
training environment, fostered by an exceptional mentoring team including Dr. Stephen Crystal (Primary Mentor)
and co-mentors Drs. Shawna Hudson, Frederick Altice, and Ayse Akincigil. The candidate will work closely with
her primary mentor to gain expertise in working with “big data” including national Medicaid claims to study state
policy natural experiments. Drs. Altice and Hudson will provide training in implementation science frameworks
and study designs including mixed methods. Dr. Akincigil will support skills development in the application of
novel advanced econometric methods relevant to observational study designs. The applicant will also complete
formal coursework and workshops in these subject areas and participate in career development activities.
Applying these newly acquired skills, this research proposes to: characterize state strategies for scaling-up
MOUD in RTPs nationally (K-99 Aim 1), define national trends in MOUD utilization trajectories during RTP
episodes in early-adopter states (K99 Aim 2), describe NJ RTP provider experiences with MOUD scale-up (R00
Aim 1), identify predictors of trajectory group membership in all IMD-waivered states and test the effects of a
New Jersey Medicaid RTP MOUD pay-for-performance incentive (R00 Aim 2). The proposed training and
research program aligns with the candidate’s long-term goal of developing an independent research program
focused on the implementation of state policy interventions targeting the scale-up of evidence-based practices
in addiction treatment settings.

Public health relevance
PROJECT NARRATIVE The opioid epidemic continues unabated, yet adoption of highly efficacious medication treatment remains low, particularly in residential addiction treatment programs. This application will promote the development of skills in an outstanding postdoctoral researcher whose research focuses on the implementation of state policy interventions targeting the scale-up of evidence-based practices such as medication treatment in addiction treatment settings. This award will provide the applicant with exceptional mentorship and training opportunities to gain skills needed during the K-99 phase to launch a successful career as an independent investigator during the R-00 phase conducting novel research aimed at reducing the public health harms caused by the opioid epidemic by improving access to evidence-based practices that promote long-term recovery from opioid use disorder.